New Ultrastructural 3D Optical Imaging of Tumor Endothelium for Cancer Nanomedicine Development

Project 2: New Ultrastructural 3D Optical Imaging of Tumor Endothelium for Cancer Nanomedicine
Development
ABSTRACT
The long-term objective of this project is to engineer a new generation of safer and more effective breast
cancer nanomedicines that improve drug delivery to tumors by efficiently overcoming the blood-tumor barrier via
transcytosis. As a first step, we propose to establish a new ultrastructural 3D super-resolution optical imaging
platform to track and quantify in a label-free manner the intracellular nanoparticle transport and transcytosis.
Nanoparticle transcytosis is a novel delivery pathway in cancer nanomedicine and may occur through two major
intracellular routes: (1) vesicle mediated intracellular transport, and (2) shuttling of nanoparticles via intracellular
tubules. However, it is unknown which pathway results in more efficient nanoparticle transcytosis and whether
these routes favor specific nanoparticle sizes to date. To differentiate between the vesicle and tubule-mediated
nanoparticle transport routes, ultrastructural 3D imaging of whole endothelial cells is needed. Our objective is to
establish a 3D super-resolution optical microscopy as a novel and unique method to understand the intracellular
pathways that nanoparticles take during transcytosis. Using our unique label-fee 3D super-resolution imaging
approach, we will test the hypothesis that nanoparticle size will determine the nanoparticle transcytosis pathway
and transcytosis efficiency in breast-cancer associated endothelial cells. For this purpose, we propose the
following two Specific Aims. Aim 1 is to establish 3D super-resolution optical microscopy of breast-cancer
associated endothelial cells in combination with label-free nanoparticle imaging. Aim 2 is to quantify nanoparticle
transcytosis in human breast cancer associated endothelial cells. In order to optimally conduct the proposed
research tasks and pursue the success of this project, the research project leader (RPL) has two experienced
mentors and also assembled a multidisciplinary research team with unique and synergistic expertise in the
nanomedicine, tumor vascular biology, super-resolution microscopy, and breast oncology. This project will
comprehensively investigate a unique imaging approach as a platform technology that can be applied to visualize
and study the nanoparticle transport in different tissues and cells in 3D at ultrastructural resolution using
conventional optical microscopes. As a result, using this novel imaging method can help design and implement
the optimal nanoparticle properties for intracellular nanoparticle transport and transcytosis to significantly
improve efficacy of the drug delivery to tumor tissues in cancer treatment. Success of this project will provide the
essential preliminary study data and scientific evidence to support the RPL to apply for the NIH R01 project (i.e.,
PAR-20-284 – Innovative Research in Cancer Nanomedicine) in the future.